Tailored dissemination and implementation of emergency care clinical decision support to improve emergency department disposition

PROJECT SUMMARY/ABSTRACT
Over 80% of emergency department (ED) patients with acute heart failure (AHF) are admitted to
the hospital, with only 10% at high-risk for in-hospital events. We developed and validated a
prediction rule (STRATIFY) that identifies ED patients with AHF that may be safe to discharge. If
successfully implemented, it will save substantial resources without sacrificing patient outcomes
and help institutions achieve goals for accountable care. Real-world adoption of prediction rules
for AHF and other conditions treated in the ED is challenged by barriers such as time-pressured
workflow, real-time data availability and quality. A solution would have considerable implications
for implementing any clinical decision algorithm. The central objective of this grant is to develop
a multilevel approach and the necessary statistical methods to close the gap in implementation
of our AHF risk prediction tool, as a model for other automated risk prediction approaches within
an electronic health records system. Through inter-disciplinary collaboration among ED
physicians, biostatisticians, qualitative research experts, implementation scientists and
bioinformaticians, we propose to rigorously develop and test a clinical decision support-based
approach including 1) robust stakeholder engagement to participate in user-centered design
and identify approaches to overcome barriers to implementation, 2) overcoming real-time data
integration challenges through statistical methods, and 3) a detailed evaluation of effectiveness
and implementation in multiple centers. Our proposal will have a broad impact on both acute
care practice and risk model implementation by closing the gap between scientific discovery and
health care delivery using risk prediction tools. Importantly, the methods developed here will
generalize to other risk prediction tools and be readily translatable to other complex ED-based
diseases such as pulmonary embolism, stroke, and COPD, thereby maximizing opportunity for
impact both scientifically and on patient care.

Public health relevance
Project Narrative Emergency department (ED) providers admit nearly all patients with acute heart failure (AHF). Some tools exist to aid in identifying AHF patients safe for discharge, but they are largely unused due to poor validation and lack of effective deployment and implementation. We developed and validated an AHF tool to safely facilitate ED discharge, and this study aims to overcome implementation barriers through a clinical decision support-based implementation strategy.